Health and Metabolism Research Core

Project Summary – Health and Metabolism Research (HaMR) Core
In vivo imaging and animal instrumentation are key elements of the proposed COBRE Center for
Transformative Research in Metabolism. The Health and Metabolism Research (HaMR) Core combines an
existing Molecular Imaging Facility with existing equipment and expertise in animal instrumentation. The goal
of the Core is to co-locate basic research in hibernation with human subject's research to promote
interdisciplinary collaboration and transformative discoveries and to adapt to the needs of the proposed
COBRE Center. We will accomplish this goal by accomplishing the following Specific Aims (SA). SA1. Support
the Molecular Imaging Facility (MIF) to provide technical assistance, expert consultation, and
sophisticated, state-of-the-art instrumentation for in-vivo and in-vitro basic and translational research. SA2. To
support project PIs and other COBRE investigators in the collection & processing of metabolic
and physiological data using animal instrumentation. SA3. To implement and continually refine our business
plan for long-term sustainable operation of the Core. The HaMR Core houses the only research dedicated
magnetic resonance facility in the UA system and in the state of Alaska, enhancing capacity for basic research
using unique Arctic animal models and for translational and clinical research in Alaskan human subjects. The
HaMR Core is an essential component of the Research Projects supported by the Phase 1 COBRE, providing
technical assistance, expert consultation, and instrumentation for basic and clinical research. The Core
includes a Molecular Imaging Facility, established in 2014, that houses a Toshiba 1.5 Tesla MRI, two NMRs
(300 and 600MHz), and a Dual-energy X-ray Absorptiometry (DXA) instrument. This facility is an important
regional resource, identified as a clinical research center site within the Northwest Participant and Clinical
Interactions Network (NW PCI). HaMR Core services include technical support and expertise in methodologies
for monitoring metabolism, via open-flow respirometry and biotelemtry, in hibernating species and laboratory
rodents.